SHORT TERM EXERCISE TRAINING ON VLDL AND LDL CHARACTERISTICS

To determine whether short term aerobic exercise training will enhance triglyceride clearance and reduce fasting triglycerides, oral fat tolerance testing, muscle and fat biopsies will be performed before and after 2 weeks of exercise by healthy men and post menopausal women.